Gestational Low-Protein diet Programming on Sex Steroid Hormone Synthesis

Offspring born to mothers with nutritional stress during pregnancy have increased susceptibility to metabolic
diseases including diabetes and hypertension during their adult life. Low protein (LP) diet during pregnancy in
rats has been shown to cause lean Type 2 Diabetes (T2D) in adult offspring. In addition, testosterone in males
and estradiol in females were also reduced in these animals. The pathophysiology of lean T2D and its
associated reductions in sex steroid hormone synthesis are poorly understood, and the mechanistic insights
are critical for the development of therapeutics. Therefore we will use this LP diet programmed lean T2D rat
model we recently developed, to investigate the mechanisms for the reduced sex steroid hormone synthesis in
males. Changes in metabolic functions of skeletal muscle and liver, and in sex steroid synthesis in gonads in
this model appears to be related to mitochondrial dysfunctions. In recent studies, we found ultrastructural
deformities with loss of cristae and appearance of giant mitochondria as well as changes in key genes involved
in various vital mitochondrial structure and function in metabolic these tissues. Impaired quality control often
results in suboptimal mitochondrial function, which affects steroidogenesis. Steroidogenesis is also regulated
by characteristics of the mitochondrial interaction with the endoplasmic reticulum (ER). Mitochondrial quality
and ER tethering are interdependent because the ER assists the mitochondria in fission and mitophagy. The
role of the intracellular cholesterol pool and its dynamics in sex steroid synthesis are also not well understood.
Pilot data from our lean T2D model suggests that mitochondrial-ER membrane contacts are reduced, and
intracellular cholesterol trafficking is altered in the gonads of LP-programmed T2D animals. We hypothesize
that LP diet during pregnancy causes impairment of mitochondrial quality, ER-mitochondrial
association, and cholesterol homeostasis in Leydig cells of male offspring leading to lower
testosterone synthesis Two specific aims are proposed. Aim 1: Determine if LP diet during pregnancy
causes reductions in mitochondrial-ER membrane contacts and mitochondrial quality in Leydig cells of male
offspring. Aim 2: Assess if LP diet during pregnancy impairs mitochondrial metabolism and intracellular
cholesterol regulation in Leydig cells of male offspring.
The studies proposed are significant because we will be the first to investigate mechanisms into the
mitochondrial dysfunction associated with reduced sex steroid production in LP programmed offspring.

Public health relevance
PROJECT NARRATIVE Programming of adult health and disease appeared to be dependent upon the fetal exposure to various in utero environmental factors. Many models of fetal programming and epidemiological data in the human suggest gender-dependent variation in the susceptibility to hypertension and Type II diabetes. This proposal investigates the mechanisms by which low protein diet duing pregnancy may regulate sex steroids in the offspring from protein restricted mothers which has reached an epidemic proportion with 1 in 10 suffering from the disease in America and is estimated that 1 in 3 Americans will have diabetes by 2050.